Connecting Primary Care to Substance Use Disorder Treatment Using a Telehealth Collaborative Care Platform

PROJECT SUMMARY/ABSTRACT
Covid-19 has increased the prevalence of substance use disorders (SUD) visits in primary care, which, when
coupled with problems of mental healthcare access for vulnerable rural populations, accentuates already
existing disparities for these patients. There is an urgent need to improve the timely identification and
management of SUD for rural primary care patients. Screening, brief intervention, and referral to treatment
(SBIRT) is an evidenced-based strategy to address SUD in the primary care setting, but it is seldom fully used.
Building on our experience in depression collaborative care (CC) management and ability to scale telehealth
outreach, we built a digitally native integrated behavioral health CC platform using a novel app and provider
platform called Senyo Health. We will utilize this SUD CC platform to complement existing CC for depression
to deliver SUD care integrated into primary care. We feel this approach will enhance SBIRT care and improve
patient-centered outcomes. If our pilot succeeds, we will scale the Senyo Health platform for SUD treatment
among rural Midwest Mayo Health System patients.
With this study, we will apply two operational strengths of Mayo Clinic to a new domain of care delivery: a
demonstrated track record of implementing integrated behavioral health CC to improve the management of
depression in the primary care setting and a demonstrated ability to rapidly deploy telemedicine service for all
psychiatric and psychological care during the COVID-19 pandemic. Through diverse stakeholder engagement,
we will explore specific barriers, facilitators, and optimal implementation processes to adapt and pilot test a
digitally native CC platform for SUD. Using a mixed implementation and efficacy study designed, we propose
enrolling patients from three clinical sites, including two rural health clinics, to evaluate the intervention's
acceptability, feasibility, and potential effectiveness. Building off this initial phase, we will expand our
intervention to include four more new clinics continuing the same mixed methods to adapt and improve
implementation processes and clinical outcomes. We will then disseminate our acquired knowledge through
research publications, web stories, and a manualized process to share with those interested in implementing a
virtual CC approach to delivering SUD services in primary care.

Public health relevance
PROJECT NARRATIVE We will test the efficacy of a digitally native Collaborative Care (CC) platform called Senyo Health to support screening, brief intervention, and referral to treatment (SBIRT) of substance use disorders (SUD) in primary care settings. We propose to use extensive stakeholder feedback and evidenced-based implementation strategies to ensure the best chance of success and generalizability to other primary care clinics.